Characterization of immunogenic and structural properties of HIV-1 envelope

DESCRIPTION (provided by applicant): There is a global urgency to develop a protective vaccine against HIV-1. Neutralizing antibodies (Nabs) can provide effective prophylaxis against HIV-1 infections. However, eliciting Nabs that are broadly cross-reactive against many antigenically diverse HIV-1 isolates has been a major challenge and it remains a critical roadblock to HIV-1 vaccine development. The primary objective of the studies being proposed is to generate novel antigens that are able to elicit such Nabs, with a long-term goal of developing a vaccine against the virus. The underlying hypothesis of this proposal is that we will be able to enhance immunogenicity of key epitopes that can elicit broadly reactive Nabs by altering the antigenic composition of HIV-1 envelope protein, as long as the immunogen is structurally intact and the epitopes are antigenically correct. To test this hypothesis, we have generated prototypic antigens based on gp41 membrane-proximal external region (MPER) and gp120 outer domain (gp120OD). Both proteins are immunogenic and can elicit Nabs against multiple primary HIV-1 isolates. Our goal is to use current and evolving understanding of biochemical, structural and immunogenic properties of the prototypic antigens to design second-generation antigens that could induce even more potent Nabs. The proposed studies are focused and hypothesis-driven, with clearly defined milestones and timelines. Successful completion of the proposed studies would represent a major advancement towards developing a protective AIDS vaccine. The proposed research Program consists of two Projects and one Core: The role of Project 1 is to design subunit envelope antigens, to produce them, and to evaluate their immunogenic properties. The role of Project 2 is to determine high-resolution structures of the antigens with a goal of facilitating the antigen design process and understanding of their immunological properties. The Administrative Core is responsible for providing the organizational management and maintaining infrastructure to support the fiscal monitoring. PROJECT 1: Antigen Design, Production and Vaccine Development (Cho, M) PROJECT 1 DESCRIPTION (provided by applicant): The major objective of the studies being proposed is to design HIV-1 envelope antigens that can elicit broadly reactive neutralizing antibodies (Nabs), with a long-term goal of developing a protective vaccine against the virus. We are taking a two-pronged approach of targeting gp41 membrane proximal external region (MPER) and the outer domain of gp120 (gp120OD). We have generated two prototypic antigens based on soluble form of gp41 MPER and gp1200D derived from M group consensus envelope. Both proteins can elicit Nabs against multiple primary HIV-1 isolates in mice. Our goal is to use current and evolving understanding of biochemical, structural and immunogenic properties of the prototypic antigens to design second-generation antigens that could induce even more potent Nabs. To achieve the goal, we have put together a strong, complementary, collaborative team of investigators with expertise in structural biology, virology, protein biochemistry, molecular biology, immunology and vaccinology. The specific aims of the Project 1 are: (1) to better define B cell epitopes on gp41 MPER, (2) to improve immunogenicity of neutralizing epitopes on gp41 MPER, and (3) to develop and evaluate immunogenicity of antigens based on gp120OD. Successful completion of the proposed studies would represent a major advancement towards developing a protective AIDS vaccine.